Zinc Protection Against Ischemia-Reperfusion Injury in Heart

Project Summary
This project is aimed to provide NIH R15 REAP research opportunities for our underrepresented graduate
students at UT Arlington, a Hispanic-Serving Institute in North Texas. During acute ischemia-reperfusion
(I/R), reactive oxygen species (ROS) is generated at the reperfusion phase and results in catastrophic
damage to heart. Thus, the administration of antioxidant agents to prevent or ameliorate ROS detrimental
effects is an active research area. The nutrient, zinc, has multifaceted antioxidant effects and has been
shown to protect against I/R injury in heart. But a safe formulation, dosage, and delivery mode of zinc have
not been established. Previously, zinc dosages yielded toxic effects (e.g., halted growth, cell death), and the
delivery mode of zinc as an ionophore across plasma membrane produced many side-effects (e.g.,
membrane damage, cell death, etc.). Our long-term goal is to establish a therapeutic zinc regimen to protect
heart against I/R injury. To progress to such human clinical trials, we must initially address two fundamental
questions: What entity besides zinc transporters regulates zinc influx in muscle cells? Can enhancement of
such intrinsic entity, without using side effect-prone zinc ionophore, protect the cardiomyocytes from I/R
injury? Toward addressing the two questions, we performed unbiased genome-scale CRISPR/Cas9-based
screening to search for such new entity. Unexpectedly, a gene on the top validated candidate list was
SLC5A3, also called SMIT1, a sodium myo-inositol transporter. SLC5A3 has never been linked to zinc
metabolism. Our preliminary data showed that knockdown of SLC5A3 negated zinc-induced protection in HL-
1 cardiomyocytes in hypoxia /reoxygenation (H/R) injury. Interestingly, hypoxic post-conditioning (PostC)
enhanced HL-1 cell survival upon H/R injury, and its beneficial effect was diminished in SLC5A3-knockdown
cells. Moreover, PostC with zinc perfusion protect the heart (in terms of reduced apoptosis, maintaining left
ventricle ejection fraction in echocardiography study) from I/R induced cardiac dysfunction in mice. The
protective function of zinc in both cultured cardiomyocytes and whole heart was blunted by a SLC5A3
inhibitor phloridzin. Based on these data, we hypothesize that SLC5A3 mediates zinc influx in
cardiomyocytes, which can be enhanced to protect heart from I/R injury. Two specific aims are
formulated to test this hypothesis: 1) to define the molecular mechanisms by which SLC5A3 mediates zinc
influx in cardiomyocytes; 2) to conduct proof-of-concept study by targeting SLC5A3-mediated zinc influx to
protect heart from I/R injury. The innovation includes: (i) the first study to show an unrecognized role of
SLC5A3 in regulating zinc homeostasis; (ii) the identification of the therapeutic potential of SLC5A3-
mediated zinc influx for heart I/R injury. As one of six founding members in Bone-Muscle Research Center at
UTA, the PI’s laboratory has required expertise, excellent resources to train PhD students in cardiovascular
physiology.

Public health relevance
PROJECT NARRATIVE Zinc is an important nutrient for health and shows potential to protect heart from stroke. This project studies a newly discovered function of SLC5A3 protein in regulation of zinc homeostasis in heart. It will help to establish a therapeutic zinc regimen to reduce muscle damage and to facilitate regeneration in heart after stroke.